Postdoctoral Training in the Radiation Sciences

[unreadable] DESCRIPTION (provided by applicant): The training of academic radiation oncologists and biologists has suffered nationwide from the paucity of formalized training programs. In this application we propose to bring together faculty associated with all three radiation oncology subspecialties (medicine, biology and physics) to establish an interdisciplinary postgraduate training program in radiation sciences. This two year program will accept two exceptional postdoctoral fellows and/or medical residents per year who are interested in an intensive research-based program. The goals of the training program are 1) To teach the trainees the theory concerning the physics governing the delivery of radiation, and the cellular biology governing its biologic effect. 2) To educate participants in the design and execution of cutting edge research in the radiation sciences. And 3) To gather together trainees from the fields of medicine, biology and physics so that they may develop a mutual appreciation for the many aspects of the study and treatment of patients with cancer. This is a particularly timely and relevant application because therapeutic radiation has become a mainstay in the treatment of many forms cancer. It is therefore imperative to develop a well trained cohort of professionals who will be responsible for the next generation of therapeutic advancements. [unreadable] [unreadable] [unreadable]